Evaluating the impact of high body mass index on cartilage deformation, cartilage metabolism, and mechanical loading in individuals with anterior cruciate ligament reconstruction

PROJECT SUMMARY
Post-traumatic osteoarthritis (PTOA) is a common and debilitating consequence of anterior cruciate ligament
injury and reconstruction (ACLR) as over half of patients develop the disease within two decades impacting their
health-related quality of life. Recent research has demonstrated the odds of developing PTOA are nearly 3 times
greater in ACLR patients with high body mass index (BMI). Unfortunately, the mechanisms underlying the
increased PTOA risk in ACLR patients with high BMI has not been directly evaluated and thus remains poorly
understood. The lack of understanding on the potential deleterious impact of high BMI in patients with ACLR
serves as the motivation and focus of this proposed research. The investigator’s long-term goal is to identify
mechanistic-driven treatment approaches to decrease the incidence and progression of PTOA after ACLR. The
objective of this F31 research proposal aims to evaluate the potential deleterious effects of high BMI on multiple
components of cartilage health in patients who are between 12 and 24 months post-ACLR. We will accomplish
these objectives by leveraging a stimulus-response strategy in which treadmill walking will be used as an in vivo
mechanical stimulus to produce a physiological response in system components governing cartilage health,
consisting of structural, biological and mechanical processes. This proposal encompasses three specific aims
to: 1) determine the negative impact of high BMI on cartilage tissue resiliency (i.e. deformation) to an in vivo
walking mechanical stimulus, 2) determine the negative impact of high BMI on biological markers of cartilage
breakdown in response to an in vivo walking mechanical stimulus, and 3) evaluate if BMI may moderate the
associations between mechanical loading and outcomes from Aims 1 and 2 (i.e. response in cartilage
deformation and biological markers of cartilage breakdown). This study is innovative, as the application of a
systems-based evaluation of cartilage health, encompassing in vivo assessments of multiple cartilage
components, is critical to characterize the negative effects of high BMI after ACLR; an approach imperative given
the complex, multifactorial nature of PTOA development. The proposed research is significant because it will
improve our understanding of modifiable factors leading to PTOA development after ACLR and provide critical
targets for future intervention strategies that may mitigate or prevent onset of PTOA.

Public health relevance
PROJECT NARRATIVE This proposed research study will evaluate the potential negative impact of high body mass index on early changes in knee joint health in patients with anterior cruciate ligament reconstruction. This information is critical for illuminating modifiable treatment targets to mitigate or prevent post-traumatic osteoarthritis development after anterior cruciate ligament reconstruction, a disease which currently has no cure. This research is relevant to NIH’s mission to foster innovative research strategies to improve fundamental understandings and diagnostic tools of human health and disability.